Novel injectable implants for long-term local controlled release of therapeutic monoclonal antibodies

PROJECT SUMMARY/ABSTRACT
Delivery of monoclonal antibody (mAb) therapeutics to hard-to-reach areas of the body such as the eye, brain,
joint and tumor tissues suffer from low drug concentrations at the target tissue, systemic side effects, or frequent
local injections. One established approach to overcome these issues is local and sustained drug exposure,
achievable with locally injectable polymer long-acting release (LAR) implants, particularly those prepared from
biocompatible and biodegradable poly (lactic-co-glycolic acid) (PLGA). PLGA has been used in > 25 FDA
approved commercial LARs. MAbs are a growing drug class with important applications in local delivery such as
age-related macular degeneration in the eye, osteoarthritis in joints and solid tumors in the brain, lung, and
pancreas. However, development of injectable PLGA LARs for mAbs is complicated by the instability of the
protein, particularly during microencapsulation and long-term drug release, and achieving desirable slow and
continuous drug release over substantial durations (>1 month). Here, we propose to develop novel and injectable
pencil lead-type PLGA implants that is capable of stably microencapsulating a variety of therapeutic MAbs while
retaining desirable release kinetics of stabilized protein in vivo for 6-12 weeks in between injection. The
technology exploits a combination of anhydrous protein encapsulation, control of microclimate pH in PLGA, and
controlling high osmotic pressures induced by necessary stabilizing disaccharide excipients. This proposal will
focus on formulation and optimization of sterile mAb/PLGA implants, using model mAbs of important clinical
significance (anti-VEGF and anti-PD1), for constant delivery of commercial therapeutic antibodies. These
formulations will be tested for their pharmacokinetics after a single injection and the implants will be assessed
for mAb stability/release directly in vivo by implant recovery.

Public health relevance
PROJECT NARRATIVE The proposed research is of high relevance to public health as these studies will generate new fundamental knowledge in drug delivery by addressing the current limitations in drug delivery systems for therapeutic antibodies. The proposed studies will result in lead sterile formulations that provide long-term slow and controlled release of stable commercial antibodies based on novel, extremely simple, efficient, scalable, cost-effective and generalizable method for encapsulating antibodies in easily injectable, biodegradable, biocompatible and FDA approved polymers.